Microsurgery Core

CORE C - SUMMARY/ABSTRACT
Our multi-disciplinary team includes the expertise of transplant immunologists with a focus on T and B cell
immunity, aging, cellular senescence and immunosenescence. Microsurgical procedures need to be kept on
an expert, high level to assure reproducibility. Animal care, and surgical training are therefore a prerequisite
for reliable experimental readouts. Transplants in older animals come with additional challenges as those
animals are more sensitive to blood loss, length of surgery, and anesthesia. Current and ongoing expertise in
microsurgery will therefore be essential for the success of our project. The overall goals of this core are: 1.) to
perform transplant surgeries for all projects under this PPG; 2.) to coordinate experiments among projects and
maximize the use of biological samples; 3.) to store and archive extra human/mouse biological samples; 4.) to
provide support for additional interventions including recurrent blood collection, intravenous infusions of
antibodies, drugs, and FRC; 5.) to provide training to microsurgeons ensuring consistent technical skills even
during changes in personnel; 6.), to supervise all regulatory aspects including Institutional Review Board
compliance in addition to coordinating data and specimen acquisition and analysis by the different projects in
this proposal.

Public health relevance
CORE C- Narrative Core C will be responsible for performing expert microsurgical procedures assuring reproducibility as a pre-requisite of reliable experimental readouts. Core C will coordinate all microsurgical procedures among Projects 1, 2 and 3 to maximize the use of samples while minimizing the number/cost of animals needed for interlocked experiments. Core C will be also responsible for education, training, and animal care of all microsurgical procedures. This core will also provide support for IACUC submissions, amendments in addition to safety and humane animal care.